URINARY MYELIN BASIC PROTEIN-LIKE MATERIAL IN PERSONS WITH MULTIPLE SCLEROSIS

The present proposal is to continue research based on the premises that small peptides of myelin basic protein originating from damaged central nervous system myelin enter cerebrospinal fluid, blood & urine of persons with multiple sclerosis & that measurement of these peptides offers a means for monitoring tissue injury.